COLLABORATIVE HUBS FOR INTERNATIONAL RESEARCH ON MENTAL HEALTH (CHIRMH)

The Contractor shall provide comprehensive clinical site and study monitoring services for the NIMH/ORDGMH CHIRMH clinical trials.